Discrete Frequency Infrared Spectroscopic Imaging for Breast Histopathology

DESCRIPTION: Technologies that can help make accurate, objective and automated decisions to aid the pathologist are sorely needed in clinical practice to improve accuracy and contain costs. The major goal of this project is to provide a practical imaging instrument for clinical and research use that can be operated by any trained person in pathology laboratories. The approach is based, first, on developing novel instrumentation and analytical methods for robust discrete frequency infrared (DF-IR) spectroscopic imaging. The instrument presents a departure from the current state of the art using a design inspired by recent advances in theory, newly-developed sources and advanced control algorithms. The integration of spectral analysis algorithms makes generation of molecular pathology data facile - without any dyes, stains or human supervision. The developed instrument and algorithms is tested in a clinical setting and results that will lead to clinical trials will be obtained. Finally, the approach is geared to bettr predict breast cancer course by utilizing the entire tumor microenvironment. As opposed to current practice, which largely relies only on epithelial cells, the new approach to using the entire tumor microenvironment has the potential to transform decision-making for patients and alter the standard practice of histologic assessment in research.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to provide a new chemical imaging instrument and methods for clinical and research use that can transform diagnosis without dyes, stains or human input. The designed instrument is high performance in terms of speed and signal to noise ratio, easily exceeding the state of the art. The instrument will be applied to address contemporary problems in breast cancer care and research by providing label-free diagnoses, stainless staining and tumor microenvironment based prognoses. If successful, establishment of the instrumentation and analytical methods here would alter the standard practice in histologic assessment of future research in cancer.